A novel dual-carrier ultrasmall nanomedicine for the treatment of stroma-rich pancreatic cancer

Abstract
Pancreatic cancer (PC) has an annual worldwide incidence of more than 495,000 cases and an
annual mortality rate of almost 460,000 cases. Most patients are diagnosed late and cannot
undergo resection and therefore rely on pharmacotherapy to extend their lives. Current
therapies offer only limited benefit due in large part to the dense stroma tissue that surrounds
and protects the tumor. Duo Oncology is developing an ultra-small nanoparticle containing,
gemcitabine and an immunomodulatory chemokine receptor type 2 antagonist to kill cancer
cells and invigorate anti-tumor immunity. These small nanoparticles, less than 30nm in
diameter, show enhanced extravasation and tissue penetration, particularly in the PC tumors
enriched with dense stroma. Further, research proposed herein will prepare DUO-307 for future
IND-enabling studies with formulation optimization, toxicology, and therapeutic efficacy using a
cutting edge ex vivo tumor explant model and a clinically-relevant mouse model of PC with
dense stroma.

Public health relevance
Project Narrative: Pancreatic cancer is one of the deadliest solid tumor malignancies. With DUO-307, Duo Oncology combines a chemotherapeutic and an immunomodulatory agent to kill cancer cells and stimulate the body’s immune response to recognize and kill the cancer. This therapy is delivered as an ultrasmall nanomedicine that can penetrate the dense stroma tissue surrounding the tumor.